Experimental Stroke Core

The overall objective of the Experimental Stroke Core (ESC) is to provide the instrumentation, expertise, resources and training for the incorporation of animal models of stroke into the research of junior investigators in the Stroke CoBRE and researchers in the greater WVU neuroscience and cardiovascular research community. This overall objective would be reached by achieving the following specific aims: Specific Aim 1: To provide the instrumentation, expertise and resources needed to produce strokes in rodent models. The ESC will be Director by James W. Simpkins (Core Director, CD) and he will be assessed by Dr. Xuefang Ren (Core Manager, CM), and James M. O'Donnell will oversee the behavioral assessment of animals. Specific Aim 2: To broadly notify the availability of these core services and resources to the greater WVU neuroscience and cardiovascular community. The availability of these services and resources are being and will continue to be presented to the WVU neuroscience and cardiovascular research community through individual meetings, seminars, presentations to neuroscience and cardiovascular group meetings and departmental seminars. Specific Aim 3: To provide processes by which users can access the core instrumentation, expertise and resources. Procedures for requesting use of core resources are described and include a brief application describing the rationale for the proposed studies and the proposed design of the study to be conducted. Specific Aim 4: To provide training in experimental stroke research. Twice per year, the CD and CM will organize trainings session on the theory, practice and outcome interpretations for potential users of the core. Specific Aim 5: To develop and implement a business plan for the ESC that will insure its sustainability. A business plan for the ESC is in development by the CD and will be reviewed by the Core Resource Management Committee of the WVU Health Science Center. Specific Aim 6: To develop formative and summative evaluation processes for the ESC. Collectively, achieving these specific aims will insure a highly functioning ESC that will provide a vital service to the Stroke CoBRE junior investigators and to the greater WVU neuroscience and cardiovascular research community.

Public health relevance
A highly functioning ESC that will provide a vital service to the Stroke CoBRE junior investigators and to the greater WVU neuroscience and cardiovascular research community and help position us for competitiveness for center and program project grant applications. Success of this ESC is a necessary component of our development of a national center for excellence in basic and translational stroke research.